Viral Testing Core

Project Summary/Abstract - Viral Testing Core
Continuous, accurate surveillance for agents of concern is an essential requirement for maintenance of specific
pathogen-free (SPF) and expanded SPF (eSPF) breeding colonies. In 2009 we transitioned from testing at off-
site laboratories to performing all screening assays at the Tulane National Primate Research Center’s (TNPRC)
Pathogen Detection and Quantification Core (PDQC). The PDQC is administratively located in the Division of
Microbiology and was established at the TNPRC in 2004. The primary mission of the PDQC is to provide
diagnostic services to the Division of Veterinary Medicine for establishing and maintaining SPF4/eSPF
nonhuman primate colonies. A secondary mission is to provide research support to investigators. The
development of onsite viral testing capabilities has resulted in reduced costs, reduced shipping of samples,
reduced turnaround time, and provided a platform for easy expansion for detection of additional agents. Quality
assurance of the TNPRC SPF surveillance program is supported by the participation of the PDQC in proficiency
panels testing from the Pathogen Detection Working Group (PDWG) of the NIH Nonhuman Primate Research
Consortium (NHPRC), and from the External Quality Assurance Program Oversight Laboratory (EQAPOL)
Luminex program. This section of the application focuses on the function of the Viral Testing Core, techniques
used for identification and detection of the target viruses, assay performance and validation, and current and
future expansion of testing capabilities.
The Aim of this core is to assure the SPF status of the colony through continued viral testing of existing breeding
colony animals and all offspring. All animals in the SPF4 colony will be tested a minimum of twice each year for
all four target viruses: Type D simian retrovirus (SRV), simian T-lymphotropic virus (STLV), simian
immunodeficiency virus (SIV), and herpes B virus (BV) for SPF4. The eSPF colony will be tested at the same
frequency for rhesus rhadinovirus (RRV), simian virus 40 (SV40), simian foamy virus (SFV), cytomegalovirus
(CMV), simian varicella virus (SVV), and lymphocryptovirus (LCV) in addition to the SPF4 agents. Infants derived
from SPF4 parents for inclusion in the eSPF colony will require quarterly testing. Characterization of the colony
beyond the targeted agents supported by the U42 grant will be funded through other sources and require the
development and use of additional assays for other pathogens of potential interest.